DAIDS Quality Assurance, Quality Control and Inspection Readiness Support Services

The purpose of this Task Order is to provide comprehensive QA/QC support services for NIAID/DAIDS to ensure DAIDS-supported clinical research is conducted in accordance with applicable regulations, and that all data are generated, documented (recorded), and reported in compliance with ICH/Good Clinical Practices (GCP) and other regulatory requirements.